High-throughput characterization and comparison of RNA localization regulatory themes in mammalian neurons and epithelial cells

SUMMARY
Eukaryotic cells contain within them a myriad of spatially distinct sites that serve a variety of functions.
To facilitate this organization, eukaryotic gene expression is routinely spatially regulated through the trafficking
and sequestration of thousands of different RNA molecules to distinct cellular locations. Misregulation of this
process leads to detrimental phenotypes in a wide range of systems, from developmental defects in Drosophila
to neurological disease in humans.
Despite this importance, our knowledge of the regulation of RNA localization is quite limited. For other
modes of post-transcriptional regulation like splicing, our understanding of how the interactions of RNA binding
proteins (RBPs) and RNA motifs lead to specific outcomes is much more mature. This relies on many years of
work by many groups that have defined the regulatory language of splicing and allows us to make predictive
and combinatorial models about how splicing is regulated across conditions and cellular environments. We
lack such an ability with regards to RNA localization, in large part because we lack the analogous “parts list”
that defines the language of localization regulation.
Generally, the effect of RBP/RNA binding on post-transcriptional regulatory processes like splicing or
RNA decay is consistent across cell types. For example, if an RBP promotes the splicing of an exon in one cell
type, it often exerts a similar effect on that exon in another cell type. However, because RNA localization is
inherently tied to cell morphology, the generality of localization regulation across cell types is unknown.
Combinations of RNA motifs and RBPs that result in RNA localization to projections in neurons are also
broadly present in non-neuronal cell types. Are these RNAs trafficked in non-neuronal cells? If so, to where?
The answers to these questions first require a better knowledge of the underlying regulatory language
of localization. The experiments proposed here are the beginnings of our efforts to define this language and
test its generality. We have developed methods to isolate and profile subcellular transcriptomes from the
projections of neurons and the apical and basal regions of epithelial cells. We will use these techniques to take
a biochemical and transcriptome-wide approach to defining RBP/RNA interactions that regulate localization in
two mammalian cell types: neurons and intestinal epithelial cells. By identifying transcripts that are mislocalized
in RBP-null cells, we will identify functional RBP/RNA interactions. Using a massively parallel reporter assay,
we will take an unbiased approach to finding RNA sequences that regulate localization. By comparing the
activities of identified functional RBP/RNA interactions across cell types, we will for the first time be able to
directly assess the generality of RNA localization. This methodical and innovative approach is the first step in
our efforts to shed light on this fundamental but poorly understood cellular process.

Public health relevance
NARRATIVE The eﬃcient subcellular localization of speciﬁc RNAs is a widespread process that is important for the proper functioning of diverse cell types across a wide range of organisms. However, our understanding of the molecular requirements that an RNA needs in order to be targeted for localization is quite sparse. This proposal uses genome engineering, subcellular fractionation, next-generation sequencing, and high- throughput screening to identify and characterize RNA elements and trans-factors that mediate RNA localization on a transcriptome-wide scale in mammalian neurons and epithelial cells and compares the requirements for localization between the two systems to assess the generality of the regulation of RNA localization.